Oxytocin: a pain disease-modifying agent in the nervous system after injury

This P01 will address fundamental gaps in knowledge that currently impede translation of findings in
the preclinical literature to improved clinical practice regarding the utility of oxytocin as a pain therapeutic and
potential disease-modifying agent to prevent the transition from acute to chronic pain. Oxytocin itself is the only
clinically available tool for translational studies in many areas – neuroprotection, anxiety, sleep, social
behaviors, addiction, and pain. Most rodent and human studies of oxytocin lack strong scientific rigor, with
only half of the clinical studies examining pain demonstrating efficacy, and we have minimal ability to
understand oxytocin effects within and across species. Since chronic pain is usually reduced acutely by
peripheral nerve block, peripheral input is necessary, but most research assumes that input is normal and pain
reflects ongoing central sensitization. We and others challenge these ideas, showing that LTMRs are
desensitized after injury whereas fast high threshold mechanoreceptors (A-HTMRs) are sensitized and
behavioral recovery coincides with return to normal function of both afferent subtypes. Importantly, oxytocin
acutely moves LTMR and A-HTMR dysfunction after injury towards normal. Pain resolves quicker in women
after cesarean delivery than other pelvic surgeries, and hypersensitivity resolves quicker in rodents when
neuropathic injury is performed after delivery, an effect blocked by inhibition of oxytocin action. These data
suggest that oxytocin may alter the process of chronic pain development after injury or surgery, and has the
potential to be not just an acute analgesic, but a disease-modifying therapeutic. Oxytocin has prosocial,
anxiolytic, and trust enhancing effects according to small studies in rodents and humans, but the circuitry and
role of these central actions on speeding recovery from pain and disability after injury are unexplored. This P01
will address these gaps and advance the field of pain research through the coordinated interactions between
the preclinical and clinical projects across 3 specific areas. The first is extrapolation of the pharmacokinetics of
oxytocin across species, such that drug exposure in relevant compartments with time are being studied in a
coordinated manner that permits interpretation of physiological or behavioral effects between rats and humans
Second is the study of primary sensory afferent physiology across species that determines how oxytocin alters
specific nerve fiber types and the key electrical properties related to pain transmission, including multiple
modes of nociceptive stimulation and their interaction. Third, we study pain behaviors beyond reflexive
responses or verbal report in animals and humans, respectively, which may offer greater translational value.
Collectively, the coordinated and synergistic nature of these studies will hopefully provide clarity on the
potential of oxytocin to mitigate chronic pain development after injury, and the context within such effects
occur.

Public health relevance
Chronic pain from injury is a major source of disability and an enormous economic and social burden. There is a clear need to identify disease-modifying therapies that prevent or reduce chronic pain after injury, including major surgery. This P01 will study oxytocin as a potential disease-modifying agent across rodents and humans, identifying critical pharmacokinetic, physiological, and behavioral measures that contribute to mitigating chronic pain development and speeding resolution of pain after injury.